Role of the transcriptional coregulator, TRIP Br2, in adipocyte metabolism

PROJECT SUMMARY Obesity develops when energy intake exceeds energy expenditure, leading to an accumulation of adipose tissue. The pandemic of excess adipose tissue is of increasing importance throughout the world. In addition to its own specific morbidities, obesity is linked to insulin resistance and the devastating metabolic syndrome of type 2 diabetes. The intricate balance of energy homeostasis is tightly regulated by a complex network of metabolic genes which respond to changing environmental conditions. Transcriptional regulation has recently been shown to extensively modulate adipocyte biology. We have discovered that a novel transcriptional coregulator, TRIP-Br2, is critical for maintaining energy homeostasis in mice. Our preliminary data from preadipocyte cell lines and TRIP-Br2 null mice leads us to propose an important role of TRIP-Br2 in adipocyte biology. Thus, the goal of this proposal is to determine the function and mechanism of TRIP-Br2 in energy metabolism in adipose tissue. I will test the hypothesis that disruption of TRIP-Br2 protects mice from diet- induced obesity through upregulation of energy expenditure with three specific aims. For Specific Aim 1, I will physically and physiologically examine the TRIP-Br2 null mice to identify the in vivo mechanism for diet- induced obesity resistance observed in TRIP-Br2 KO mice. Completion of Aim 1, which will take place during K99 phase, will provide me with training in aspects of in vivo and ex vivo adipose physiology necessary to independently complete the R00 phase. For Specific Aim 2, which will span the K99 and R00 phases, I will determine the molecular targets of TRIP-Br2 that contribute to the diet-induced obesity resistance phenotype in TRIP-Br2 null mice using genome-wide gene and protein expressions together with bioinformatics analysis. Completion of the subaim of Aim 2 proposed during the K99 phase will provide me with the training in analysis of complex datasets with computational biology necessary to independently to complete Aim 2 during the R00 phase. For Specific Aim 3 (R00 phase), I will determine the composition of TRIP-Br2 transcriptional regulatory complex in adipocytes. Completion of this aim will allow me to link the TRIP-Br2 regulatory network with known gene regulatory system in adipocyte. These experiments are novel in that they combine mouse genetic, physiologic, and molecular biology approaches to examine the mechanistic role of TRIP-Br2 in energy metabolism. These studies will provide novel insights into the transcriptional regulation of adipocyte function and could potentially be used for developing therapeutic targets for obesity.

Public health relevance
Project Narrative Obesity is a critical health problem in the US because it leads to fatal complications. These studies will determine the mechanisms contributing to high fat diet-induced obesity resistance in our mouse model. Understanding the gene targets will facilitate development of therapeutic strategies. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Obesity develops as a consequence of an imbalance between energy intake and energy expenditure, leading to an accumulation of adipose tissue. The intricate balance of energy homeostasis in mammals is tightly regulated by a complex network of metabolic genes in response to changing environmental conditions; however, the mechanisms that regulate this network in the context of obesity are not fully understood. Proteins known to regulate metabolic gene networks include transcriptional coregulators which interact with transcription factors and with diverse regulatory proteins to either activate or repress the transcription of key regulatory genes. Recently, it has become evident that transcriptional coregulators, such as PGC-1a, SRC-2, and RIP-140 are involved in the regulation of adipocyte biology. Another transcriptional coregulator, TRIP-Br2 (also known as Sertad2), belongs to a novel family of plant homeodomain (PHD) zinc finger- and/or bromodomain-interacting proteins. TRIP-Br2 has been reported to regulate cell cycle progression by interacting with the E2F/DP1 transcription complex. We have recently observed that the levels of transcriptional coregulator, TRIP-Br2, are consistently higher in the adipose tissues of mice fed a high fat diet and in genetic models of obesity (e.g. ob/ob mice). Preliminary studies in pre-adipocyte cell lines using gain- and loss-of-function models of TRIP-Br2 indicate that this transcriptional coregulator is involved in the regulation of lipolysis and oxygen consumption. Furthermore, we observed that disruption of TRIP-Br2 in mice results in protection from diet-induced obesity and insulin resistance despite similar food intake. In this proposal, I will explore the role of TRIP-Br2 in obesity, modulation of lipolysis and regulation of energy metabolism in adipose tissue. Elucidation of the mechanism(s) by which TRIP-BR2 regulates adipocyte biology in obesity is critical for understanding the molecular mechanisms that lead to excess adipose tissue accumulation, and will likely contribute to the development of novel treatments for obesity. The specific aims are to: 1: Determine the mechanisms of obesity resistance in TRIP-Br2 null mice. Our preliminary data indicate that TRIP-Br2 plays critical roles, in vivo, in the development of obesity. To test this hypothesis, I will characterize TRIP-Br2 null mice, and determine the mechanism for the resistance to diet-induced obesity in vivo. In addition, I will use isolated primary preadipocytes and adipocytes from WT and TRIP-Br2 null mice to determine the impact of TRIP-Br2 ablation on adipocyte differentiation, lipolysis, lipogenesis and the rate of oxygen consumption/thermogenesis in isolated primary adipocytes and mouse embryonic fibroblast. 2: Identify the molecular targets of TRIP-Br2 in adipocyte. This aim will determine the molecular targets of TRIP-Br2 that contribute to the resistance to diet-induced obesity in TRIP-Br2 null mice. Except for the previously reported E2F/DP1 complex, little is known about TRIP-Br2's transcriptional partners. To identify target genes, brown and white adipose tissues (identified in Aim #1) will be subjected to gene expression microarray and proteomic analyses. Potential targets will be confirmed by in vitro experiments using a differentiated adipocyte cell line. The candidate TRIP-Br2 targets will be reconstituted in TRIP-Br2 KO mouse embryonic fibroblasts or knocked down in WT mouse embryonic fibroblasts using siRNA to confirm functionality. The nucleic acid binding site for the TRIP-Br2 complex will be defined using chromatin immunoprecipitation-DNA sequencing (ChIP-Seq). 3: Identify components of the TRIP-Br2 transcription complex. Using stably differentiated adipocytes that express epitope- tagged TRIP-Br2, I will: 1) determine whether TRIP-Br2 physically associates with the E2F/DP1 complex in adipocytes, and comprehensively identify the components of the TRIP-Br2 transcriptional complex; 2) confirm candidate TRIP-Br2 interaction partners and begin to study their role in adipocyte biology. The proposed studies will allow me to determine the mechanisms of TRIP-Br2 action in adipose tissue, its target genes and the transcriptional complex modulating energy expenditure in the obesity-resistant TRIP-Br2 null mice.